MALDI-TOF MS - OADDL equipment

Project Summary/Abstract
Oklahoma Animal Disease Diagnostic Laboratory (OADDL) is a FDA-VetLIRN source
laboratory and has been providing bacterial isolates for the AMR project for the past several
years. We are requesting partial funds to purchase a Matrix Assisted Laser Desorption
Ionization – Time of Flight Mass Spectrometer (MALDI-TOF MS) which is a critical equipment
that will help OADDL in serving the diagnostic needs of Oklahoma and continue to successfully
assist Vet-LIRN in its various missions.

Public health relevance
Project Narrative This proposal is a request for partial funding to purchase a Matrix Assisted Laser Desorption Ionization – Time of Flight Mass Spectrometer (MALDI-TOF MS). The MALDI-TOF MS equipment will be used at the Oklahoma Animal Disease Diagnostic Laboratory (OADDL) for accurate and rapid identification of bacteria and is essential for applications in animal disease diagnostics and VetLIRN research projects.